Phosphoinositide Signaling in the Cytosol and Nucleus

PROJECT SUMMARY. This research seeks to understand spatial phosphoinositide signaling (PI) mechanisms
in the cytosol and nucleus. These pathways have broad implications for cancer, neurodevelopmental disorders,
diabetes, and several congenital diseases. In the cytosol, agonists, such as EGF (and many others), activate
signaling pathways that control most cellular functions. In the nucleus, these pathways are separate from known
membrane compartments but control stress responses that impact DNA repair, cell survival, and other events.
Agonists activated PI3K signaling occurs through the IQGAP1 scaffold that assembles multiple pathways
including the PI 3-kinase and Erk pathways. Yet, how the IQGAPs assemble specific signaling pathways is not
understood. We will focus on the assembly of the full PI 3-kinase pathway on IQGAPs. This includes the
assembly of the PI 4-kinase (PI4KIII), type I PIP 5-kinase (PIPKI), PI3K, Ras, PDK1 and Akt into the
scaffold. Remarkably, we show that IQGAP2 and IQGAP3 also assemble the PI 3-kinase pathway components
but with different outcomes. IQGAP2 is tumor suppressor in cancer cells whereas IQGAP1 and IQGAP3 promote
PI3K signaling and cell proliferation. Here, we will explore how receptors stimulate the assembly of the IQGAPs
signaling pathways with an emphasis on the EGF receptor and IQGAP1-PI 3-kinase and Erk pathways. We will
emphasize spatial PI 3-kinase signaling at endosomal compartments at proximity to microtubules by linkage with
microtubule associated protein 4 (MAP4) that interacts with IQGAP1 and PI 3-kinase. The link between the
cytosolic and nuclear PI signaling is the PIPKI, which generates PIP2 in the cytosol and nucleus
Nuclear PI signaling remarkably is not associated with membrane compartments. We showed that a nuclear
poly(A) polymerase, Star-PAP (for speckle targeted PIPKI regulated-poly(A) polymerase), associates with
PIPKI and is activated by phosphatidylinositol-4,5-bisphosphate (PIP2). Star-PAP controls ~40% of genes and
is regulated by many signals. Recently, we have shown that PIPKI also binds to the tumor suppressor p53,
and that p53 is a PIP2 effector. The binding of PIP2 stimulates p53’s interactions with other nuclear factors that
control p53 function. Both Star-PAP and p53 are also regulated by inositol polyphosphate multikinase (IPMK)
that generates phosphatidylinositol-3,4,5-trisphosphate (PIP3) associated with p53, and nuclear PTEN that
dephosphorylates this PIP3. We have identified Star-PAP and p53 as two key effectors of nuclear
phosphoinositide signaling during stress signaling. This proposal will focus on the mechanism and impact of this
stress pathway on Star-PAP functions. Remarkably the PIPn is so tightly associated with Star-PAP and p53 that
it is stable to SDS-PAGE suggesting a covalent linkage and we will explore how PIP2 is linked to Star-PAP and
p53. Is this covalent or a very tight interaction that is resistant to denaturation? Our findings indicate new avenues
for potential therapeutic control of both the cytosolic and nuclear PI pathways as these pathways have
fundamental implications in many disease processes but with an emphasis on cancer.

Public health relevance
PROJECT NARRATIVE Agonist-activated PI3K signaling and nuclear PI signaling in stress have fundamental roles in many biological functions including in the immune system, cardiovascular and neuronal diseases, and cancers. Here we have discovered the regulation of PI3K signaling by a novel scaffolding molecule, IQGAP1 which brings all components of PI3K pathway in close functional proximity for concerted and spatial generation of the second messenger phosphatidylinositol-3,4,5-trisphosphate in any subcellular compartments, including plasma membrane and endosomes. PIPKI scaffolded by IQGAP1 in cytosol is also present in the nucleus. In the nucleus, PIPKI and its PIP2 product controls gene expression through a poly (A) polymerase Star-PAP and the tumor suppressor p53. PIP2 associated with Star-PAP and p53 serve as substrate for a novel nuclear PI 3- kinase, which is counteracted by nuclear PTEN. This has identified a novel nuclear PI stress signaling pathway encompassing PIPKI, Star-PAP, p53, IMPK and PTEN. These cytosolic and nuclear PI signaling pathways have clear diagnostic and therapeutic applications in cancer and neuronal diseases.